Children's Research Institute Hematology Research Training Grant

There is a critical shortage of investigators in health care who are prepared to combine clinical expertise with
research inquiry that will advance the health and treatment of diseases affecting children, in particular those with
hematological disorders and those with a variety of diseases who require transfusion and/or novel cell-based
therapies. This renewal application will continue our highly collaborate multidisciplinary, interinstitutional program
which couples transformative mentored research experiences with didactic education and career development
in basic, translational, and clinical research in four content areas of importance to the National Heart, Lung and
Blood Institute (NHLBI) with an emphasis on transfusion medicine, cell-based therapies, vascular biology and
inflammation. Over two to three years, five postdoctoral trainees who are completing fellowships in hematology-
oncology, allergy-immunology, cardiology, critical care medicine, neonatology, pulmonology or similar pediatric
subspecialty fields will submit competitive applications to this program. If selected, they will be engaged in
learning cutting edge techniques including molecular, genetic, cellular, device and community-based research
methods using a multidisciplinary training program with 26 preceptors from Children's National (CNH), its
Research Institute (CNRI), The George Washington University (GWU), and the intramural programs of the NIH.
Acquisition of skills in cell therapy and transfusion medicine will include the principles of Good Manufacturing
Practice (GMP), gene editing and cell/tissue expansion/engineering. These laboratory-based experiences will
be coupled with formal training in hypothesis building, data analytics, biostatistics, grant preparation,
communication and writing skills in many cases leading to a Master's degree. Leveraging existing collaborations,
we will prepare pediatric trainees from diverse subspeciality backgrounds who will ultimately lead research
teams, compete successfully for grant support, and become the next generation of pediatric researchers focused
on the pathogenesis and pathobiology of disorders affecting children requiring blood and cell-based therapies
and who will create and implement new treatment paradigms and oversee the clinical management of
hematologic, cardiovascular, pulmonary and inflammatory disorders.

Public health relevance
PROJECT NARRATIVE The Pediatric Hematology and Transfusion Medicine Multidisciplinary Research Training Award (PHTMMRT) at Children's National is a rigorous 2- to 3-year mentored program of career development and research training for post-doctoral pediatric subspeciality trainees who have demonstrated potential for and interest in pursuing research careers particularly in the areas of red cell biology, and sickle cell disease, cell therapies/immunobiology, infection/inflammation and coagulation/vascular biology. The ultimate goal of PHTMMRT is to develop independent clinician-investigators and academic leaders in the scientific domains of relevance to The National Heart, Lung, and Blood Institute.